Admixture mapping of mosaic copy number alterations for identification of cancer drivers

PROJECT SUMMARY/ABSTRACT
Background: Somatic mosaicism arises due to the clonal expansion of a cell with an acquired mutation, which
leads to genetically distinct sub-populations of cells in an organism derived from a single zygote. As a clone
proliferates, its subclones can accumulate further molecular changes that seed cancer. A better understanding
of acquired point mutations and copy number changes in these clonal expansions can help elucidate the
earliest stages of cancer development. Studies of tissues from healthy individuals have found that those with
clonal mosaicism in blood, specifically copy number alterations (CNAs), have a ~10-fold higher risk of
developing hematological malignancies, thus underscoring the translational potential of mosaicism studies for
the development of improved risk assessment and cancer prevention strategies. Research up to now has
mainly focused on persons of European ancestry. My own preliminary results show differences in the genomic
landscape of CNAs between individuals of African American or Latino ancestry when compared with
Europeans. Understanding these differences and the underlying molecular mechanisms is critical in order to
include these still under-researched populations in translational mosaicism studies for early detection and
prevention of hematological and potentially other cancers. Proposed Research: Aim 1 is to address the great
need for comprehensive studies of mosaicism in American minority populations through a large-scale analyses
of CNAs in African American and Latino whole genome sequencing (WGS) data sets. This approach will
enable a robust comparison of mosaicism profiles across populations; WGS will allow for joint analysis of
CNAs and somatic point mutations to gain insights into mechanisms that underlie different rates and subtypes
of hematological malignancies across populations. Aim 2 is to develop novel methods to combine CNA and
haplotype level ancestry data for detection of variants associated with increased mosaicism rates. I will use
these methods to identify genetic variants that are associated with mosaicism and with increased cancer risk in
Latinos and African Americans. Candidate: I have led projects to discover and analyze acquired CNAs in
thousands of non-malignant tissues – first of their kind studies for pathologically normal and premalignant
tissues – as well as in cancer tissues that complement these. This expertise and my established track record in
the development of computational methods for human/cancer genomics, will ensure the successful completion
of these aims. As larger volumes of normal tissues are molecularly profiled, I will be able to extend methods
developed in Aim 2 to additional normal tissue types, and conduct integrative omics analyses. I will follow up
this work and the associated publications with an R01 proposal focused on translational applications of mosaic
mutations in normal tissues as markers for cancer risk assessment, early detection, and prognosis. The K22
award will be fundamental as I launch my independent investigator career, offering management and grant
writing training, helping to hone my skills as a mentor/PI and establish a long-term funded research program.

Public health relevance
PROJECT NARRATIVE Clonal mosaicism in the blood has not been comprehensively investigated in African American and Latino populations. We will assess this biomarker of cancer risk in these populations through the development of novel methodology that will enhance integrative analysis of mosaic mutations, germline variation, and ancestry. A better understanding of mosaicism in these under-studied populations will allow for more targeted cancer risk assessment and early detection.